Junctophilin-2 in Cardiac Fibroblasts

PROJECT SUMMARY / ABSTRACT
Cardiac fibrosis is a wound healing response to heart injury that plays a critical role in structural and electrical
remodeling of the heart. It is a common feature in most heart diseases, particularly following ischemic events
like myocardial infarction (MI). Cardiac fibroblasts (CFs), the prominent nonmyocyte population in heart tissue,
are important for maintaining normal cardiac function, facilitating wound healing, and mediating remodeling after
injury. CFs proliferate and migrate to the affected areas, where they deposit excess extracellular matrix proteins
to aid in tissue repair. Calcium (Ca2+) signaling is pivotal in regulating key aspects of fibroblast biology, including
migration, differentiation, and gene expression. However, the mechanisms that establish Ca2+ homeostasis in
CFs and their role in cardiac fibrotic remodeling remain poorly understood. In pilot studies, we found,
Junctophilin-2 (JP2), a structural protein crucial for organizing the junctional couplings between the T-tubule
plasma membrane and the sarcoplasmic reticulum (SR) in cardiomyocytes, is uniquely expressed in CFs and is
vital for maintaining their Ca2+ homeostasis. Further work suggests that JP2 deficiency in CFs impairs scar
formation and exacerbates heart function after MI, likely due to impaired Ca2+ regulation. Based on these
preliminary findings, we hypothesize that JP2-mediated Ca2+ signaling is essential for CF responses to ischemic
challenges and that defects in this signaling pathway contribute to aberrant fibrotic remodeling following injury.
This project will employ advanced molecular, physiological, and biochemical techniques, along with innovative
mouse models, to investigate the specific mechanisms through which JP2 influences CFs and its role in injury-
induced cardiac fibrosis. The anticipated outcomes of this research include providing novel knowledge on JP2's
physiological and pathophysiological functions in CFs, shedding light on the mechanisms driving cardiac fibrosis
and heart dysfunction after injury. Ultimately, these insights may pave the way for the development of new
treatments targeting cardiac fibrotic process and improving heart health outcomes.

Public health relevance
PROJECT NARRATIVE Cardiac fibroblasts play a crucial role in initiating fibrotic processes that lead to the formation of scar tissue, replacing damaged cardiomyocytes and helping to maintain heart function following myocardial injury. This project aims to investigate the important role of junctophilin-2, a protein unexpectedly identified in cardiac fibroblasts, in the fibroblast response to injury and its potential implications for heart disease.